Research Development Core

The Research Development Core is a required (and essential) component of the San Antonio (SA) Nathan
Shock Center. The core provides support for research career development of junior faculty and for more senior
investigators who wish to apply their expertise in related research areas to basic aging research. To accomplish
these aims, the core administers the Access to Core Services for investigators at any institution in the country
and the Pilot Project Program for local investigators. The Access to Core Services program invites applications
from other institutions to collaborate with researchers at the SA Shock Center, enabling scientists anywhere in
the aging research community to take advantage of the unique resources available at this center. These activities
of the Research Development Core serve to coordinate Research Career Development Activities for
junior/new investigators and scientists entering geroscience at any level. For career development activities, the
core coordinates its activities with the Administrative/Program Enrichment Core.
The Research Development Core's Specific Aims are to:
1. Facilitate research in the basic biology of aging across the country by providing funding that makes the
core services of our center available to all qualified investigators on a competitive basis. The new Access
to Core Services program provides a means for any investigator at any institution to use the services of any of
the cores (Animal, Pathology, Pharmacology, Integrative Physiology of Aging) for their innovative research in
geroscience.
2. Administer a Pilot Project Program for local investigators that aims to expand the scope of research in
the basic biology of aging at UTHSCSA. The program will continue to support the large numbers of faculty
members at the institution with research in geroscience, particularly those newly recruited to the university.
3. Assist new investigators in research career development and assist investigators at all levels to pursue
novel ideas in aging research. The core will provide a variety of assistance with grant and project development,
as well as aspects of career advancement. Mentoring will be carried out by the core leadership in association
with senior faculty of the Barshop Institute and will be coordinated with mentoring activities of the awardees'
departments and home institutions.
4. Evaluate the success of these programs by tracking grants and publications of awardees; recommend
changes to our Executive Committee when necessary. The overall metrics of the success of the core's activities
are the awardees' success in publishing high-impact papers and obtaining sustained extramural grant support.
In association with the Administrative Core, the Research Development Core will maintain continuing records of
the success of awardees and make recommendations for adjustment of the programs as needed.